Defining the Pathogenesis and Prognosis of Human Acute Interstitial Nephritis

Acute interstitial nephritis (AIN), resulting from drug exposure, infection or autoimmune disease, is the cause
of acute kidney injury (AKI) in up to 20% of patients who undergo a kidney biopsy. Even though we currently
have 2 clinical interventions available to treat patients with AIN (withdrawal of the offending drug and
corticosteroids), 40-60% of patients with AIN go on to develop chronic kidney disease (CKD) even when
appropriately treated. Kidney damage in AIN is believed to result from immune-mediated tubular injury that
eventually leads to fibrosis and permanent kidney damage.
The recent dileniation of the immune underpinnings of multiple autoimmune diseases and cancers has led to
the development of targeted therapies that exhibit improved efficacy and less toxicity compared to
corticosteroids. Therefore, an analysis of the immune infiltrate and resulting resident cell (tubular and vascular)
responses that provides pathogenic understanding of the specific immune events that initiate and propogate AIN
should lead to development and/or repurposing of targeted therapies that are more effective at resolving AIN
and preventing the progression to CKD, as well as potentially less toxic.
Data from several groups, including our own, suggest that CD4+ T-helper cells (particularly the TH2/TH9
subsets) are potential drivers of AIN. We have found that TH2/TH9 cytokines IL-5 and IL-9 and some cells of type
2 immunity, mast cells and eosinophils, are higher in the urine or kidneys of patients with AIN. Based on these
data, it is our hypothesis that TH2/TH9 T-helper cells in the kidney itself play an important pathogenic role in
promoting tubular or vascular injury in AIN. We will test this hypothesis by performing a quantitative evaluation
of the kidney immune infiltrate and accompanying tubular and vascular response in humans with AIN. We will
use existing kidney biopsies, adjudicated by 3 nephropathologists as exhibiting AIN, from two university health
centers (Yale and Johns Hopkins), as discovery and validation cohorts for this study. To perform the quantitative
analysis we will use an imaging technique called Imaging Mass Cytometry (IMC) that supports the simultaneous,
spatially-preserved quantification of up to 42 antibodies on a single tissue section. We have an existing library
of 27 validated kidney and immune antibodies and have developed a machine learning protocol to rapidly and
accurately quantify and localize all cells in the human kidney identified using IMC.
We will first increase our validated antibody panel and optimize our IMC protocol for use in the study of AIN
(SA 1). We will then use IMC to identify, quantify and localize the immune and resident cell responses in 30 AIN
cases and 60 non-AIN control biopsies from Yale (discovery cohort), followed by 30 AIN cases and 60 non-AIN
controls from JHU (validation cohort, SA 2). Finally, we will define the relationship between cellular determinants
of AIN and recovery of kidney function as well as response to steroids (SA3). Our findings will not only lead to
identification of novel druggable targets in AIN, but also lead to improving clinical histological diagnosis of AIN.

Public health relevance
Acute Interstitial Nephritis (AIN) is an important cause of kidney dysfunction, and can lead to chronic kidney disease in many patients. We know that AIN occurs as an immune response in the kidney to certain drugs or infections, but do not have a clear understanding of the cell sources of the inflammation or the tubular and vascular responses. This proposal is designed to define these immune events in human kidney biopsy samples left over after clinical diagnosis has been completed, and to determine how they relate to the development of chronic kidney disease.